Research Training in Age-Related Cognitive Disorders

This is an application for the third renewal of an institutional training grant in Age-Related
Cognitive Disorders, first funded by NIA in 2007. The imperative to find better treatments
for age-related cognitive disorders requires individuals who are trained in state-of-the-art
approaches to these disorders, with a focus on integration and communication across
disciplines. To accomplish this, a multidisciplinary program has been developed with four
special emphasis areas: (1) Clinical Studies of Aging and Age-Related Cognitive
Disorders; (2) Population Studies of Aging and Age-Related Cognitive Disorders; (3)
Imaging Studies of Aging and Age-Related Cognitive Disorders; and (4) Animal Models
of Aging and Neurodegeneration. We are requesting funds to maintain the current level
of support for the next funding cycle at 3 pre-doctoral and 3 post-doctoral positions.
There are 26 participating faculty, drawn from the Departments of Neurology, Psychiatry,
Radiology, Pathology, Neuroscience, Epidemiology, Psychology & Brain Sciences, and
Mental Health at Johns Hopkins University. These departments span the School of
Medicine, the School of Public Health, and the School of Arts and Sciences at Johns
Hopkins University. There is also a faculty member from Morgan State University, an
Historically Black College/University in Baltimore. Each trainee will continue to have a
primary and secondary mentor. A core didactic program has been developed for both
the pre-doctoral and post-doctoral trainees. This framework has allowed us to recruit
high-quality trainees, who are diverse, have been highly productive, yielding graduates
who are in excellent positions at respected institutions. We believe this program
addresses a critical need for training in the area of age-related cognitive disorders, which
will ultimately benefit the growing number of older persons who suffer from these
conditions.

Public health relevance
This is a training program pertaining to age-related cognitive disorders. The growing number of older persons who suffer from these conditions requires training young researchers in state-of-the-art approaches to these disorders, with a focus on integration and communication across disciplines.